Activation of non-apoptotic cell death by the DNA damage response

PROJECT SUMMARY
The overarching goal of this project is to understand how non-apoptotic cell death is activated by the DNA
damage response (DDR). In response to genomic insult, the DDR activates DNA repair and cell cycle arrest to
resolve the damage and promote cell survival. Alternatively, in cases of severe damage, the DDR will activate
apoptotic cell death. These critical pro-survival and pro-death responses are all regulated by p53. The centrality
of p53 in the DDR allows cells to quickly and flexibly respond to different types of DNA damage. However, in the
absence of p53, what outcome is predicted by this model? While we might expect that p53 removal abrogates
both cell cycle arrest and apoptosis, many p53-mutated cancers are still able to execute cell death in response
to DNA-damaging drugs. This suggests the presence of an additional and heretofore undescribed pathway
linking the DDR to cell death. We found that DNA damage is also capable of inducing non-apoptotic cell death.
Furthermore, non-apoptotic death is preferentially activated in cells that lack p53. Our strategy for characterizing
this novel DNA damage-induced non-apoptotic death was to perform a whole-genome CRISPR screen.
Genome-wide CRISPR screens do not typically identify death regulatory genes. To overcome this limitation, we
devised a new experimental and computational method for calculating the drug-induced death rate of each
single-gene knockout. Based on the results of our screen, in Aim 1 we will test the hypothesis that ROS and
mitochondrial permeability transition (MPT) are required for DNA damage-induced death in the absence of p53.
We will use CRISPR/Cas9 mediated knockout to compare DNA damage-induced MPT to canonical MPT. We
will monitor activation of MPT using fluorescence microscopy, and use TEM to characterize mitochondrial
morphologies. Our CRISPR screen also identified TGF-β signaling as a negative regulator of DNA damage-
induced non-apoptotic death. In Aim 2, we will identify TGF-β pathway components that contribute to the
suppression of non-apoptotic death, and determine the generalizability of this knowledge across cell lines. We
will extend this exploration to an in vivo mouse model of cancers generated with and without functional p53. Our
characterization of DNA damage-induced non-apoptotic death will improve our understanding of how p53-
mutated cancers respond to chemotherapeutics. Ultimately, we hope that this work will improve our ability to
predict which cancers will respond to DNA-damaging drugs, as well as which death pathways can be targeted
to enhance treatment efficacy.

Public health relevance
PROJECT NARRATIVE Despite our expansive knowledge of the DNA damage response, we currently have very little ability to predict how cancers will respond to conventional DNA-damaging drugs. This proposal aims to characterize unexpected mechanisms by which DNA-damaging chemotherapies preferentially kill cancer cells. A comprehensive understanding of DNA damage-induced non-apoptotic cell death is crucial for designing effective cancer therapies.